Cortical and thalamic mechanisms of selective auditory attention

SUMMARY ABSTRACT
There have been many recent developments in invasive and non-invasive techniques for modulating brain
operations. However, these techniques typically cannot be efficiently used beyond “proof of concept”
experiments since the cellular-network origins of the most basic functions in the brain are not known. Part of
the reason for this is that while cognitive neuroscientists have learned a lot about the principles that govern
brain operations, and computational modelers have made leaps and bounds in creating models of nearly every
brain circuit, these two fields remain only sparsely connected. Our proposed project will bridge the gap
between cognitive neuroscience, electrophysiology, and computational modeling by measuring neuronal
activity on multiple spatial scales in behavioral experiments, and connecting these data to detailed
computational models of the auditory thalamocortical system. This process will provide specific predictions for
the neuromodulation of auditory system function and form a solid base for novel therapeutic approaches.
Our project focuses on defining the cellular-network underpinnings of three distinct mechanisms of auditory
perceptual processes, which are utilized for speech processing. The first is the flexibility of neuronal
oscillations in the delta-theta bands that endows them with the capability to dynamically adapt their cycles to
the quasi-rhythmic structure of naturalistic auditory stimulus sequences, including species specific
vocalizations and speech. The second mechanism that supports efficient auditory processing is oscillatory
phase reset, which enables the precise tracking of stimulus sequences by neuronal oscillations supporting,
amongst other things the figure-ground segregation of attended auditory streams. The third fundamental
mechanism for processing continuous auditory stimulus streams is parsing, which enables the brain to
segment and group acoustic elements so that they form units that are interpretable by the brain. These three
mechanisms form the basis of the complex computations needed to make sense of the auditory environment.
We will perform concurrent thalamus-cortex electrophysiological recordings in macaques to determine the
spatiotemporal organization of neuronal activity patterns supporting the above described fundamental auditory
processing mechanisms. The data collected during behavioral tasks will inform our detailed thalamocortical
computational model, which will in turn provide precise predictions on efficient neuromodulation approaches to
induce, or temporarily inhibit the neuronal activity patterns underlying distinct auditory processes like stream
segregation or parsing. Besides advanced time-resolved single unit and neuronal ensemble activity analyses,
we will be able to verify the effectiveness of neuromodulation based on behavioral biases.
The model based, targeted neuromodulation techniques developed by our proposed projects will pave the way
for novel therapeutic approaches in the treatment of neuropsychiatric and developmental disorders that are
hallmarked by deficits in the dynamical properties of neuronal oscillatory systems.

Public health relevance
Narrative Using data obtained with electrophysiological recordings spanning multiple spatial scales, coupled with advanced data analyses, we are developing a detailed model of the brain’s auditory thalamocortical circuits and their hallmark neuronal oscillatory patterns, which support distinct functions, like auditory selective attention and speech segmentation. We will use the model and experimental data to better understand the brain and the characteristic neuronal deficits underlying a variety of brain diseases, including schizophrenia and autism spectrum disorders. This improved understanding will lead to the development of novel, precisely targeted neuromodulation methods that will first be tested within the model and then could be used to restore intricate neuronal oscillatory dynamics altered in numerous neuropsychiatric and developmental disorders.